Injectable cell-free piezoelectric scaffold to treat osteoarthritis in large animal models

Abstract
Millions of American suffer from osteoarthritis (OA) while the repair of large or major cartilage defects in severe
OA is still a significant challenge. Current medicines including analgesics and anti-inflammatory drugs only
alleviate the symptoms but do not completely cure the disease. The gold standard treatment is to use
replacement auto- and allo- replacement cartilage grafts. These grafts however suffer from the problems of donor
site morbidity, immune-rejection, infection and especially, limit of tissue supply. As such, regenerative
engineering approaches, which rely on biomaterial scaffolds to construct “engineered” cartilage grafts, have
emerged as an important field. Despite many encouraging results, the clinical use of engineered cartilage grafts
has been limited due to the (1) the ineffectiveness to regenerate hyaline cartilage which can serve as a load-
bearing tissue, (2) the toxicity and adverse events of growth factors or seeded stem cells which are often used
to promote the cartilage regrowth, and (3) the invasive surgical procedure to implant the grafts. As an alternative
to biochemical cues, electrical stimulation (ES) has been shown to significantly promote bone and cartilage
growth, and can be used in combination with a biomaterial tissue graft to enhance tissue regeneration.
Piezoelectric materials with an exciting ability to generate electricity under applied pressure, could be appealing
to create self-powered electrical stimulators which can be mechanically activated to electrically induce cartilage
re-growth. In this regard, the PI group has pioneered a novel piezoelectric nanofiber scaffold made of Poly-L-
lactide (PLLA, a well-known safe erodible polymer) which can be implanted into cartilage defects and produce
electrical cues under ultrasound activation to electrically drive cartilage re-growth. To avoid the invasive
implantation surgery, we also developed an injectable piezoelectric scaffold which is comprised of a traditional
collagen hydrogel and cryo-sectioned piezoelectric PLLA nanofibers. The hydrogel however provides only a
modest chondrogenesis, preventing its ability to heal challenging load-bearing cartilage defects. Herein, we
propose to (1) study a new injectable piezoelectric nanocomposite hydrogel scaffold, based on the piezoelectric
PLLA nanofibers and magnesium oxide nanoparticles (MgO NPs) which could offer a significantly enhanced
chondrogenesis, superior to the piezoelectric PLLA hydrogel alone, and (2) investigate how this piezoelectric
MgO/PLLA nanocomposite hydrogel scaffold can be used to promote the healing of major load-bearing cartilage
defects in large animal models. The success of this proposed work will be the key step towards a clinical trial for
testing this novel injectable self-powered piezo-scaffold treatment in human OA patients with severe cartilage
damages.

Public health relevance
Narrative Millions of American suffer from osteoarthritis, a painful joint disease caused by damages of cartilage tissues which cushion bone impacts during the joint movement. The current treatment methods including the use of analgesics or anti-inflammation drugs only alleviate the symptoms but do not cure the disease while surgical approaches are invasive. Here, we propose a novel piezoelectric nanocomposite hydrogel scaffold which can be injected into cartilage defects via a minimally invasive manner and receive ultrasound activation to effectively promote cartilage healing for the treatment of osteoarthritis.